Nociceptive Mechanisms Underlying Sickle Cell Pain

Project Summary:
Pain is the most common clinical complication of sickle cell disease (SCD) from infancy through adulthood.
Individuals with SCD experience severe, recurrent acute pain during a vaso-occlusive episode (VOE) that can
last for days. Patients also develop lifelong chronic pain at steady state that occurs in addition to ongoing acute
pain episodes. The acute and chronic pain in SCD is currently treated almost entirely with opioids, which have
serious adverse side effects, addiction risk, and in some cases fail to completely alleviate pain or even
exacerbate it further. The mechanistic causes of the intense, episodic pain that drives patients to seek
emergency health care have been minimally investigated and present a major gap in understanding and
treating acute SCD pain. Moreover, the causes of chronic SCD pain at steady state are insufficiently
understood. Our proposal will tackle these critical gaps by using data derived from patients with SCD to drive
our hypotheses that will be directly tested in a preclinical SCD mouse model. Metabolomic analysis of patient
plasma showed that free heme was elevated in patients with SCD at steady state compared to healthy
controls. Consistent with this, our preliminary data in SCD mice showed that scavenging heme with the heme
binding protein haptoglobin alleviated steady state hypersensitivity. Furthermore, plasma taken from patients
with SCD seeking acute pain care showed that TNFα gene transcription was highly increased in a reporter cell
line. Consistent with this, our preliminary data in SCD mice showed that inhibition of TNFα using the FDA-
approved TNFα antibody infliximab completely alleviated VOE-associated mechanical hypersensitivity. Taken
together, these compelling data support our hypotheses that free heme instigates chronic, steady state pain in
SCD through direct access to the dorsal root ganglia (DRG), while TNFα drives acute VOE-associated SCD
pain. Furthermore, we hypothesize that both free heme and TNFα also mediate persistent and acute pain,
respectively, by initiating immune cell infiltration into DRG sensory neurons that contribute to their sensitization.
By exploring these mechanisms in the context of SCD pain, we may uncover novel therapeutic targets that
provide more effective analgesia and avoid the harmful effects of prominently prescribed opioid therapy used
for SCD pain. These studies may also reveal more about pain mechanisms present in other pain conditions
where heme and TNFα are also dysregulated, including fibromyalgia, spinal disc herniation, arthritis,
inflammatory bowel disease, ankylosing spondylitis, and psoriasis.

Public health relevance
Project Narrative: Patients with sickle cell disease (SCD) suffer from severe acute and chronic pain, the exact causes of which are unknown. We will determine whether free heme drives steady state pain and whether the cytokine TNFα drives acute vaso-occlusive episodic pain by sensitizing sensory neurons through direct and immune-mediated inflammatory signaling. If our studies are positive, they will suggest that TNFα inhibitors which are FDA- approved should be tested in clinical trials with SCD patients.